Communication and Dissemination Core

Abstract – Communication and Dissemination (C&D) Core – Core C
The benefits of new knowledge and innovative research resources that improve understanding of ADRD care
and consequences will not reach their full potential without being accessed, understood, and acted upon by
appropriate audiences including the lay public, government and other policy-makers, and scientists. The
Communications & Dissemination (C&D) Core is the engine of Hopkins’ Economics of Alzheimer’s Disease &
Services (HEADS) Center activities to build community and promote awareness of Center research
resources, investigators, their expertise, and Center research findings to both internal and external
audiences. To meet its goals, the C&D Core has the following three Specific Aims: AIM 1: To sustain and
strengthen the HEADS Center communications and dissemination infrastructure. The Core will extend the
Center’s reach and impact through our enhanced Center website, newsletter, communication channels, and
social media presence - platforms to increase awareness about our Affiliates and their expertise, our research
resources, and our findings, among internal and external audiences. AIM 2: To promote and coordinate
Center-wide capacity-building activities including the monthly HEADS Center Seminar Series that is
organized by the Admin Core, and relevant working groups as gateways to the HEADS Center for
investigators within and external to Hopkins, thus facilitating connections to collaborators, training materials,
and ADRD and aging research resources. AIM 3: To cultivate relationships with audiences across disciplines,
career stages, and institutions – including policy makers and the general public – through Annual Scientific
Convenings in partnership with academic groups, professional and advocacy organizations, and policymakers
with missions intersecting with the HEADS Center themes The Core is structured to maximize
communication and networking among all Center components; with HEADS Center Affiliates and the larger
Hopkins community; and with external scientific, policy, advocacy, and service communities. As such, the
C&D Core will interface closely with all HEADS Cores. The C&D Core will provide the leadership and
coordination to engage diverse audiences – e.g., policy makers, members of the advocacy community, and
key organizations committed to improving the lives of persons with ADRD and their families – to ultimately
increase the value of research evidence by making it understandable, accessible, and usable in guiding
strategic clinical and policy decision-making.